Improving Biomaterial Implant Tolerance with Damage-Associated Molecular Pathway (DAMP) Molecule Attachment

PROJECT SUMMARY
A key determinant of the success of a biomaterial implant is its interactions with the host immune system, which
often determines whether the biomaterial will survive and/or provide any benefit to the host. Every biomaterial
implantation initiates a wound environment of varying intensity and activation of host immunity is dependent on
leukocyte stimulation via pattern recognition receptors (PRRs) on the cell surface. PRRs recognize both foreign
pathogen-associated molecular patterns (PAMPs) that are common on microorganisms (signaling infection) and
damage-associated molecular patterns (DAMPs) that arise from cell stress, damage, or death (infection
independent). Due to their role in a non-pathological tissue response, we believe surface treatment of implants
with DAMP molecules can greatly diminish fibrotic bioimplant response and can even counteract the signaling
of more inflammatory PAMP molecules. We have invented a biomaterial platform with highly tunable surface
chemistry (to allow DAMP attachment) and an extremely low inherent fibrotic biomaterial response called
Microporous Annealed Particle (MAP) scaffolding. We will use a murine model of injection-implant of the MAP
scaffolding to identify DAMPs that instruct productive wound healing and/or limit the negative consequences
PAMP-mediated biomaterial rejection. This will have important consequences for our understanding of the
wound healing environment and represent proof of principle experiments for a tool that can be harnessed to
improve wound healing, induce scar remodeling, and limit negative immune responses at bioimplant sites.

Public health relevance
PROJECT NARRATIVE A negative immune response causes both biomaterial implant rejection and pathological wound healing associated with scar formation leading to impaired tissue function. This project uses a novel tool to identify immune signaling molecules that 1) promote a productive wound healing response and 2) limit inflammatory responses signaled by microbial contaminants common to surgery rooms. These tools have the potential to improve wound healing, induce remodeling of developing scars, and reduce bioimplant rejection.